Assembly and Function of the Yeast Spore Wall

7. PROJECT SUMMARY/ABSTRACT
Fungal infections are a significant public health problem because they can be lethal in
immunocompromised individuals. A major difficulty in treating these infections is the small number of effective
antifungal drugs. Existing treatments cause significant side effects and frequently result in the appearance of
resistant strains. The cell wall is an essential organelle of a fungal cell and contains many fungal-specific
components that are potential targets for anti-fungal drugs. For example, one major class of antifungal drugs
targets a key enzyme in cell wall assembly. Therefore, understanding how the cell wall is constructed is
essential for identifying new targets for antifungal drugs. In the budding yeast Saccharomyces cerevisiae, the
haploid genomes produced by meiosis are encapsulated by a multi-layered spore wall, which allows spores to
resist a variety of environmental stresses. The inner layers of the spore wall are composed of mannan and β-
glucan, similar to the vegetative cell wall. The outer layers of the spore wall are comprised of the
polysaccharide chitosan, the polyphenol dityrosine and triglycerides. These outer spore wall components are
absent from vegetative cell walls and are primarily responsible for the stress resistance of spores. The
combination of (1) chitosan, (2) a polyphenol, and (3) neutral lipids is a conserved structural module in fungal
cell walls, including those of pathogenic fungi. The budding yeast spore wall therefore provides an excellent
model system to study the construction and regulation of this structural module. This grant is focused on how a
conserved set of lipid-droplet localized proteins regulates the assembly of this fungal cell wall structural module
both in S. cerevisiae and the pathogen Candida dubliniensis.

Public health relevance
8. PROJECT NARRATIVE The fungal cell wall is the interface between the cell and its environment. In pathogenic fungi, proper function of the cell wall is important for survival in the host, and drugs targeting cell wall assembly are effective antifungal agents. The spores of baker's yeast Saccharomyces cerevisiae are not pathogenic but are surrounded by a complex coat, the spore wall, which includes many of the same components found in the walls of pathogenic fungi. We are using spore wall formation as a model system to unravel the biochemistry and genetics of fungal wall assembly. This application focuses on understanding how a conserved set of proteins localized on lipid droplets promote the formation of a specific structural feature in the cell wall.